IRACDA at Texas A&M University

PROJECT SUMMARY
IRACDA@TAMU is a partnership between Texas A&M University (TAMU), a historically white R1 university that
has recently achieved the status of a Hispanic-Serving Institution, and Prairie View A&M University (PVAMU),
an HBCU that has recently achieved the status of an R2 university. By adopting community-based mentoring
models that emerged from Hispanic and Black communities, TAMU and PVAMU faculty from groups
underrepresented in the biomedical workforce developed the Research-Intensive Community model as an
alternative to the traditional 1-on-1 mentoring model. Leveraging the sustainability of multilevel mentoring and
the productivity of diverse undergraduate research teams, this model fully integrates research, education, and
leadership to train participants, produce research, and transform institutions. We will pursue four objectives to
form a unique postdoctoral training program: 1) Prepare Scholars to initiate a research program and develop
technical and operational skills by working with faculty research mentors. In Year 1, Scholars, guided by both
research and instruction mentors, observe PVAMU classes and work in TAMU labs to lay the foundation for an
adaptable research program that can be deployed in both research- and teaching-intensive institutions. 2)
Prepare Scholars to sustain a research program that integrates high-impact teaching practices into the lab
by leading undergraduate research teams. In Year 2, Scholars join the IRACDA Research Leadership Program
and learn to amplify their research productivity by effectively leading diverse undergraduate research teams. 3)
Prepare Scholars to sustain a teaching program that integrates research projects into the classroom by
teaching inclusive course-based undergraduate research experiences (CUREs). In Year 3, Scholars continue in
the IRACDA Research Leadership Program and learn to establish CUREs at PVAMU that sustains their research
and expands research capacity of their instruction mentors. 4) Prepare Scholars to establish and direct
research education programs that cultivate inclusive, safe, and supportive research-intensive communities. In
Year 4, Scholars join the IRACDA Directors Program and learn to direct scalable research leadership programs
that bridge institutions. By the end of the grant period, 12 IRACDA Scholars will have gained the technical,
operational, and professional skills to become independent academics that develop sustainable research
platforms at either research- or teaching-intensive institutions. They will have become highly sought-after change
agents that create inclusive research education programs and equitable research-intensive communities
bridging research-intensive universities and HBCUs. PVAMU will have increased research capacity by
establishing the multilevel Panther Research Program and the first undergraduate Biomedical Research
Certificate at an HBCU. The IRACDA@HBCUs Coalition will support program alumni and Scholars in other
IRACDA programs as this adaptable, diverse, sustainable, and scalable model is propagated to other HBCUs
and their R1 partners.

Public health relevance
PROJECT NARRATIVE This proposal seeks to leverage the research and teaching strengths of TAMU, a large R1 institution and PVAMU, a partner R2 institution, and the premier HBCU in Texas, to train a diverse group of skilled scientists to excel at both teaching and research using a successful research-intensive community mentoring model. It is expected that this IRACDA-trained cadre of scientist-educators will partner with undergraduate institutions to increase science literacy and interest among historically underserved student populations and serve to recruit a new generation of scientists into biomedical and health research.